Diversity Supplement

PROJECT SUMMARY This is a request for a Research Supplement to promote Diversity in Health-Related Research for grant R21EY030609. Specifically this Supplement is requested to support my graduate student, Angelica (Angie) Godinez for a period of 13 months (August 1 2020 – August 31, 2021) to complete her Ph.D.

Public health relevance
PROJECT NARRATIVE This is a request for a Research Supplement to promote Diversity in Health-Related Research for grant R21EY030609. The proposal was reviewed by the SPC Study Section in February 2019 and received an impact score of 13. Specifically this Supplement is requested to support my graduate student, Angelica (Angie) Godinez for a period of 13 months (August 1 2020 – August 31, 2021) to complete her Ph.D. The specific research that Angelica will perform is directly related to Aim 2 of the parent grant, i.e., to assess the role of fixational eye-movements in saccadic latency, and visual search. This aim is fully in line with her desire to apply her background and knowledge of the oculomotor system and human factors to address questions of plasticity in adults with abnormal visual development (amblyopia). Angelica is a Chicana, and the first in her family to go to College, where she succeeded in completing both a B.S. in Psychology and an M.S. in Human Factors in Ergonomics. She entered the Ph.D. Program in Vision Science at UC Berkeley in 2015, and was awarded a Chancellor's Fellowship – this is an incredibly competitive fellowship, awarded to exceptional applicants who also advance the Regents' goals for diversification of the academy. She is interested in a research and teaching career, and the training plan is aimed at providing important opportunities for Angie's career development as a productive researcher and educator.